Interpretation Modification Program for Social Phobia

DESCRIPTION (provided by applicant): Social phobia is characterized by severe social anxiety leading to functional impairment (Schneider et al., 1992). Despite its high prevalence (13%, Kessler et al., 1994) over 30% of individuals with social anxiety who need treatment do not receive treatment (Olfson, et al., 2000) and 40% of individuals who present for treatment do not respond (39%, Heimberg, et al., 1998;42%, Liebowitz et al., 2005). Thus, there is a clear need to develop highly effective and efficient treatments for GSP. Reducing negative interpretation of social events is an efficacious treatment for SP because:1) benign interpretations is associated with improvement in social anxiety after treatment (e.g., Franklin, Huppert, Langner, Leiberg, &Foa, 2005), 2) negative interpretations are implicated in the pathogenesis of SP (e.g., Rapee &Heimberg, 1997), 3) SPs have more negative interpretations of social events than non-anxious controls and individuals with other anxiety disorders (e.g., Amir et al, 1998), and 4) this bias ameliorates after successful treatment (e.g., Stopa &Clark, 2000). Therefore, changing negative interpretations is an efficacious treatment for SP, and current cognitive- behavioral therapies use cognitive restructuring (CR) to target negative interpretations and replace them with more benign interpretations (Heimberg, et al., 1998). The goal of the current application is to test a new computerized treatment for SP that is designed to change negative interpretations. We chose a computerized intervention to increase efficiency and ease of delivery. We chose to test this intervention in GSP because interpretation bias is especially relevant to this clinical population. The long-term goal of this project is to improve service delivery using a widely available and economical intervention for GSP. More specifically, we will test three hypotheses in this application: 1) Individuals with GSP completing the Interpretation Modification Program (IMP) will show a reduction in their negative interpretation, 2) Participants in the IMP will show a decrease in their social anxiety symptoms, 3) Change in social anxiety symptoms will be mediated by the change in interpretation scores, suggesting that interpretation change reduced social anxiety symptoms. Pilot data (n=34) suggest that this intervention is efficacious. Thus, we aim to develop further and validate this highly efficient treatment for changing interpretations as a cost-effective treatment for patients with social phobia. Social phobia has high prevalence (13%, Kessler et al., 1994) and leads to functional impairment (Schneider et al., 1992). However, over 30% of individuals with social phobia do not receive treatment (Olfson, et al., 2000) and 40% of individuals who present for treatment do not respond (39%, Heimberg, et al., 1998;42%, Liebowitz et al., 2005). The goal of this project is develop and test a new computerized treatment for social phobia.